Characterization of acetaldehyde-protein adducts in alcohol-associated liver disease

Project Summary/Abstract
Ethanol consumption has been on the rise throughout the COVID-19 pandemic and one of the major
consequences has been a surge in alcohol-associated liver disease (ALD), especially severe alcoholic
hepatitis (sAH). sAH is a life-threatening condition with 30-day patient mortality greater than 30%, limited
treatment options, and often requires a liver transplant. There is an urgent need to identify novel mechanisms
of ALD progression that are potential targets for treatment. The ethanol metabolite acetaldehyde (AcH) is
known to form adducts on lysine residues within proteins, which affect protein function. Many proteins are
known to bind to AcH, but no one has characterized the overall composition or downstream effects of these
protein modifications on the pathogenesis of ALD. Albumin is one of the major proteins known to bind to AcH,
and these AcH adducts mostly occur on the many exposed lysine residues throughout the albumin molecule.
The fact that a single albumin can bind many AcH molecules combined with albumin being the most abundant
protein in the liver and circulation means that albumin may act as a “sponge” for excess AcH. Therefore, any
decrease in albumin levels may lead to increased modification of other proteins, having deleterious effects on
ethanol-induced organ injury. My preliminary data shows that plasma albumin levels are decreased in heavy
drinkers compared to control subjects in the absence of liver dysfunction. In albumin-deficient mice, ethanol
feeding leads to decreased lymphocyte accumulation in the liver, but the mechanism is unknown. This project
is designed to test the overarching hypothesis that albumin alters the distribution of AcH-protein
adducts after ethanol consumption, modulating lymphocyte function in ALD. In Aim 1 (K99 phase) I will
receive training from my mentor, Dr. Bin Gao, to determine how AcH and albumin regulate lymphocyte
function. In Aim 2 (K99 phase), I will receive training in proteomic methods and analysis from my committee
member Dr. Fritz to characterize the AcH-protein adductome in immune cells and albumin-deficient mice. In
Aim 3 (R00 phase), I will use the training from the K99 phase to analyze public proteomic datasets and identify
specific AcH-protein adducts that are present in patients with ALD. I will utilize cellular models to determine
how these modifications impact immune cell and hepatocyte functions in the context of ALD. This project will
provide a framework for how AcH-protein adducts modulate ALD using albumin as a model protein. The
training provided by this grant will provide the PI with a strong foundation to achieve his long-term goal of
identifying systemic mediators of ethanol-induced liver injury to develop therapeutics that protect against
alcohol-induced injury in multiple ways. The NIAAA will provide an ideal environment for cross-disciplinary
training and the necessary resources to transition to independence.

Public health relevance
Project narrative: The toxic ethanol metabolite acetaldehyde (AcH) is known to form AcH-protein adducts that affect protein function, but the roles of these adducts in alcohol-associated liver disease (ALD) is unclear. Albumin is the most abundant protein in circulation and is known to bind AcH. Our preliminary data indicates that albumin is decreased in heavy drinkers, which may affect the distribution of AcH-protein adducts. Albumin-deficient mice exhibit impaired lymphocyte function after ethanol feeding, but whether this is due to increased AcH-protein adduct formation is unclear. Therefore, the proposed work will evaluate the effect of albumin on the AcH- protein adductome. The study is expected to provide a framework for how AcH-protein adducts can modulate immune cells and ALD pathogenesis.